Mechanisms and Treatment of Hajdu Cheney Syndrome

PROJECT SUMMARY/ABSTRACT
Notch receptors play a critical role in cell fate decisions and in the regulation of bone remodeling, either
directly or through the induction of their target genes, namely Hairy Enhancer of Split (Hes) and Hes-related
with YRPW motif (Hey). Hajdu Cheney Syndrome (HCS) is a devastating disease characterized by
developmental abnormalities, acroosteolysis and bone loss with fractures. HCS is associated with mutations in
exon 34 of NOTCH2 upstream of the PEST domain leading to NOTCH2 stabilization and gain-of-function. We
created a mouse model of HCS (Notch2tm1.1Ecan) that presents with osteopenia due to enhanced
osteoclastogenesis and bone resorption. These events are secondary to an increase in receptor activator of
nuclear factor Kappa B ligand (RANKL) by cells of the osteoblast lineage, and to direct effects of NOTCH2 in
cells of the myeloid lineage. In this lineage, the expression of HES1 is induced by NOTCH2 and the
inactivation of Hes1 in the osteoclast lineage reverses the in vitro and in vivo phenotype of HCS mutants.
Moreover, HES1 induces osteoclastogenesis directly and as a result causes osteopenia in vivo. This reveals a
previously unrecognized function of HES1 in osteoclast differentiation and function that will be explored as part
of the proposed research. An additional goal of the proposed work is to develop ways to correct the skeletal
manifestations of HCS by targeting the mutation with Notch2 antisense oligonucleotides (ASO), a strategy that
would be applicable to other genetic disorders of the skeleton. Our specific aims are: Aim 1) To determine the
role of HES1 in osteoclastogenesis. Our goals are to induce and inactivate Hes1 specifically in cells of the
osteoclast lineage to determine its contribution to osteoclast differentiation and bone remodeling as determined
by microcomputed tomography and histomorphometry; Aim 2) To establish that the Notch2tm1.1Ecan mutation can
be targeted. We will determine whether the Notch2tm1.1Ecan mutation can be downregulated specifically and the
Notch2tm1.1Ecan skeletal phenotype ameliorated by the administration of antisense oligonucleotides targeting the
Notch26955C>T mutation; and Aim 3) To validate the mechanisms of the HCS phenotype and ASO approach in
NOTCH2 mutant-induced pluripotent (iPS) cells. To this end, we created NOTCH2HCS mutant iPS cell lines
to study the impact of the mutation on osteoclastogenesis and the efficacy of ASOs in downregulating
NOTCH2 mutant alleles. The goals of the proposed work are to understand the mechanisms and develop
specific antisense technology to treat the skeletal manifestations of a devastating NOTCH2-associated
disease.

Public health relevance
PROJECT NARRATIVE These investigations will clarify the mechanisms responsible for Hajdu Cheney Syndrome, a rare but devastating disease characterized by craniofacial manifestations, lysis of the distal phalanges and bone loss with fractures. The proposed work will serve to establish the function of an important Notch target gene that is responsible for the manifestations of the syndrome. In addition, the work proposed will target the mutation in models of human disease, as a means to treat and cure a rare but devastating clinical disorder. The work will form the basis for treating other genetic disorders affecting the skeleton.